Modeling the Impact of Novel Tobacco Product use on Smoking and Long-Term Health Outcomes

PROJECT 1 Abstract
Under the Family Smoking Prevention and Tobacco Control Act, the Food and Drug Administration (FDA) is required to
show that any new rule to regulate the marketing, sale, or content of tobacco products is “appropriate for the protection of
the public health.” To provide the FDA with a framework to assess the potential health impacts of tobacco regulations,
Project 1 will harmonize and extend well-established Center for the Assessment of Tobacco Regulations (CAsToR)
tobacco control simulation models to examine the impact of FDA regulatory actions on future trends in cigarette, cigar,
electronic nicotine delivery systems (ENDS), and other novel tobacco product (ONPs) use and associated health
outcomes. This project will focus on Behavior (Aim 1), Impact Analysis (Aims 2 and 3), and Health Effects (Aims 2 and 3)
as Scientific Domains (RFA-OD-22-04). Project 1 has three aims. Aim 1. Characterize longitudinal patterns of use and
tobacco use transitions of cigarettes, cigars, and ENDS, individually and in combination. Oral nicotine, heated
tobacco products (HTPs), and ONPs will be considered as data on their use becomes available. Using nationally
representative health surveys, literature reviews, and tobacco use transitions estimates, we will extend a previously
developed framework to examine tobacco use transitions between regular cigarette and ENDS use to include cigars,
HTPs, and ONPs. We will develop tobacco use transition parameters to distinguish between exclusive, former, dual use
and switching patterns for each product. Aim 2. Develop simulation models of the use patterns of cigarettes, cigars,
ENDS, and other tobacco products in the US and their health implications. We will expand the CAsToR simulation
models (i.e., SimSmoke, Mendez and Warner, Microsimulation, and SAVM) to incorporate product use, health outcomes,
and all-cause mortality risk of cigars, HTPs, and ONPs. Population tobacco use transitions in the models will be modeled
through sex- and age-specific initiation and cessation rates for each product and switching rates between products. Each
model will be calibrated and validated against prevalence rates by age and sex from surveys for each product type. Aim
3. Model the impact of existing and potential regulations on tobacco use patterns and all-cause mortality
associated with cigarette, cigar, ENDS, and other novel tobacco product use. For all models, we will create the capability
to examine how past and future FDA policies will impact combustible and novel nicotine product use and associated
health outcomes. We will develop best estimates and credible ranges of the policy effect on each product’s initiation,
cessation, and switching rates. We will consider variations in policy effect sizes by age, sex, population groups, and other
demographics. We will initially focus on the relationship between cigarette and ENDS use, and then incorporate cigar use.
Comparative analyses of the four models’ predictions will be conducted to refine the likely best-case, worst-case, and
most likely projected scenarios to better assess regulatory impacts. The resulting models will have the capacity and
flexibility to rapidly incorporate new data and consider new regulatory policy options as they emerge.